ENDOCANNABINOID REINFORCEMENT OF PHYSICAL ACTIVITY

PROJECT SUMMARY/ABSTRACT----------------------------------------------------------------------------------- ---
Greater than 80% of US adults do not meet physical activity recommendations leading to years of preventable
disability, diminished well-being, early death, and annual healthcare costs estimated at upwards of $300 billion.
Despite strong medical evidence that sedentary behavior is a health risk, current methods to increase physical
activity rely on willpower and/or knowledge (e.g., doctors’ suggestions, public media) have been unsuccessful.
Thus, there are currently no effective long-term methods to increase physical activity participation. Individuals
who experience pain-relieving, destressing, antidepressant, and/or euphoric psychological affects during
physical activity are more likely to participate. The source of these reinforcing affects has been linked to
endogenously produced endocannabinoids. We hypothesize that enhancing the action of endocannabinoid
receptors (CB1) during physical activity will increase these positive affective states leading to greater long-term
participation. Under the mentorship of Drs. Jerrel Yakel and Guohong Cui at the National Institute of
Environmental Health Sciences, along with the support of ten established scientists with expertise in the
proposed studies, this Pathway to Independence Award offers an opportunity for postdoctoral fellow, Dr. Ayland
Letsinger, to explore this hypothesis through three specific aims: SA1 (K99): To determine whether
endocannabinoid release in the ventral tegmental area reinforces wheel running, SA2 (K99): To determine
whether amplification of CB1 activity response to endocannabinoids by a CB1 positive allosteric modulator
(PAM) will increase wheel running in mice that are innately low wheel runners, and SA3 (R00): To determine
whether amplification of CB1 activity response to endocannabinoids via a CB1 PAM will increase wheel running
in mice that have undergone an intervention to reduce wheel running. These findings will have a profound impact
by identifying a target that can be acutely modulated to enhance long-term voluntary participation, thereby
significantly improving human health. Moreover, this grant will support Dr. Letsinger’s transition to becoming an
independent scientist in the field of addiction research. The award provides opportunities for training in
photometry and pharmaceutical applications, comprehensive instruction in addiction-related study design and
theory, mentorship from a diverse group of scientists in academia and government, and the production of high-
quality data. This technical and professional foundation will support future research endeavors in addiction and
related fields, enhancing Dr. Letsinger's potential to make significant contributions to science.

Public health relevance
PROJECT NARRATIVE----------------------------------------------------------------------------------- ------------------ Despite strong medical evidence underscoring the health risks associated with physical inactivity, most U.S. adults do not meet the minimal physical activity guidelines. There are currently no effective methods for promoting sustained participation in physical activity. This project aims to examine the potential of the endocannabinoid system in reinforcing voluntary physical activity.